Research Capacity Building by a Clinician Scientist within the Michigan Cancer Research Consortium- National Community Oncology Research Program

PROJECT SUMMARY/ABSTRACT
This Clinician Scientist project is proposed by Elie Dib, MD, MS, FACP, a member of the
Michigan Cancer Research Consortium (MCRC)-National Community Oncology Research
Program. MCRC is well established and based at the Trinity Health Ann Arbor (THAA) Hospital,
which is a small academic medical center, associated with the nation’s fifth largest health
system. Dr. Dib practices as a medical oncologist within THAA and Chelsea Hospital, a joint
venture with Michigan Medicine. Over 40 trial sites and 140 investigators conduct research as
part of MCRC. Dr. Dib concurrently serves as Adjunct Faculty Lecturer at Johns Hopkins
University, teaching in the areas of Cancer Biology and Therapeutics and Individualized
Genomics and Health. Dr. Dib has been a highly productive MCRC co-I since 2016, contributing
the following major deliverables: a) site PI for over 60 protocols enrolling 800 patients across
MCRC; b) enrolling investigator for 200+ patients completing NCI trials; c) co-founder and Vice
Chair of Alliance Immuno-Oncology Committee; d) community co-chair of seven Alliance trials
and representative to the NCI iMATCH initiative. He is also serving a 3-year term with the NCI
Genitourinary Cancers Steering Committee.
Aims of the project will be to continue established and successful clinical trials activities and
gain protected research time to complete the following: a) contribute to newly-funded MCRC
initiatives aimed at increasing the rate of clinical trials enrollment by minority and underserved
individuals; b) launch safety lead-in work and more Phase I trials at MCRC’s most capable sites;
c) evaluate and help adopt AI and PROs tool(s) for improving efficiencies in research such as
patient screening and building capacity to use real-world evidence; d) continue collaboration
development within MCRC community sites, that are joint ventures with Michigan Medicine, to
bring a wider range of NCI-funded studies to community settings. In completing this work, Dr.
Dib will provide essential knowledge, skills, and abilities as a community-based oncologist to
NCI clinical trials initiatives. This project fills a gap for NCI by bringing a highly-qualified
community oncologist into the Clinician Scientist program. Nationally, most oncology care is
delivered in the community, often in tandem with high-functioning clinical trials programs. Thus,
his perspective and experience are representative of the broader cancer care community. His
work will have high impact for all of MCRC, Alliance, NCI, and the large population of patients
and families who access cancer care outside of major academic medical centers.

Public health relevance
PROJECT NARRATIVE This project, to increase NCI clinical trials capacity, within the Michigan Cancer Research Consortium (MCRC)-National Community Oncology Research Program, will be the first to be completed by a Clinician Scientist (Elie Dib, MD, MS, FACP) who works with patients and families in a community setting. Nationally, the majority of cancer care is delivered in the community setting, making it essential to have representation from this type of research leader. Outside of MCRC, significant impact will also be felt by the Alliance Research Base and NCI, due to Dr. Dib’s deep contributions to clinical trials protocols, committees, and initiatives focused on immuno-oncology, precision oncology, and prevention and symptom intervention.